Double Danger: Additive Effects of Dementia and Additional Serious Illness on Patient, Caregiver, and Health System Outcomes

RP1 Project Summary:
Background: Healthcare spending is highly concentrated among a small seriously ill population and, despite
high spending, quality of care for this group is often low, marked by poor communication, high burden of pain
and other symptoms, and preference-discordant treatments. A key subset of this seriously ill population,
persons with dementia (PWD), may experience the greatest burden of serious illness due to dementia’s long
course of illness, progressive functional impairment, and high degree of caregiver strain, the impact of which is
often magnified among vulnerable and underserved subgroups. These issues are not well characterized over
the course of illness and very little is known about the experience of those with both dementia and another
coexistent serious illness, such as advanced cancer or heart failure.
Aims: This project aims to contribute rich, prospective patient-centered evidence examining the longitudinal
experience of PWD and another coexistent serious illness and their families with additional focus on disparities
in outcomes among socially vulnerable and underserved populations. We will: 1) examine among PWD the
prevalence of another coexistent serious illness over time until death; 2) evaluate differences in treatment
intensity (i.e., total Medicare costs, total hospital days, days away from home) annually and cumulatively until
death, among person with dementia alone and those with dementia and another serious illness; and 3) assess
differences in patient and family experience of care (i.e., caregiving hours, caregiver strain, care-setting
transitions, nursing home admission and in-hospital death), among persons with dementia alone and those
with dementia and another serious illness. In each aim, we will study differences across vulnerable subgroups.
Methods: We will assemble a novel, prospectively-framed sample of PWD combining the nationally-
representative Health and Retirement Study (HRS) and National Health and Aging Trends Study (NHATS)
cohorts and follow them through the full course of dementia until death. Using currently available data, we will
capture over 7000 individuals at the interview when probable dementia was first identified, and combine their
longitudinal survey data with Medicare claims data through time of death, to investigate differences in
treatment intensity and experience of care between those with dementia alone and those with dementia and
another serious illness (e.g., advanced heart failure).
Public Health Significance: Older adults with dementia and another coexistent serious illnesses and their
families are at risk for suffering due to low-quality, high-cost care, yet little prospective data on their
experiences exist. This project will examine the longitudinal experience of PWD and their families beginning
when dementia was first identified, and compare these experiences to those with another serious illness, such
as advanced cancer or heart failure. By examining patient and families’ experiences prospectively and over the
full course of illness, we can begin to appropriately target the interventions needed to improve care.